Peptide regulation of blood-feeding and mating physiology in mosquitoes

Project Summary PD/PI: Laura B. Duvall PhD
Mosquitoes are obligate blood-feeders that pose increasing threats to global public health by
spreading diseases, including Zika and malaria, among humans. Innate behaviors, including
blood-feeding and mating, play key roles in vector biology and undergo dramatic changes
influenced by environmental factors and internal state but we know little about the physiological
changes underlying the behavioral readout. Our work focuses on understanding how
neuropeptides regulate organismal physiology in mosquitoes. Specifically, how these peptides
influence blood-feeding and utilization and post-mating responses.
After a full meal of blood, female mosquitoes suppress their drive to bite humans for several
days until they have matured and laid eggs. Behavioral suppression consists of several phases
that are influenced by fluid regulation, nutrient sensing and satiety, and egg development.
Although it is clear that these pathways influence each other, exactly how these individual
components combine to produce the full expression of behavioral suppression remains
unknown. We will use a combination of pharmacological and genetic techniques to ask how
these pathways interact with each other on a signaling level as well as an anatomical level.
Female mating responses are strongly regulated by peptide signals transferred from males to
females. These signals prevent the female from accepting subsequent mates, ensuring the first
male fathers all of her offspring, and allow her to allocate nutritional resources for reproduction.
Using high-throughput cell-based screening techniques to pair ligands with receptors we will
identify key receptors in the female that mediate post-mating responses and find small molecule
drugs that act on them. We will map the anatomy that underlies post-mating responses using
cutting-edge genetic techniques that enable us to label and manipulate the cells that express
these receptors.
These findings will increase our mechanistic understanding of how neuropeptide signaling acts
on anatomical circuits to modulate chemosensory perception and motivated behavior.
Additionally, these results will provide the basis for innovative approaches to mosquito control
since receptors that affect mating and biting could be “weaponized” against mosquitoes to
disrupt these behaviors. Directly targeting behaviors that contribute to the spread of diseases
offers an effective vector control solution by preventing transmission of all of the pathogens
carried by these animals.

Public health relevance
Project Narrative PD/PI: Laura B. Duvall PhD Mosquitoes spread pathogens by biting humans to feed on their blood and using the protein from these meals to develop eggs and reproduce. This research project will characterize neuropeptide signaling pathways and anatomy that underlie the physiological changes that control blood-feeding and mating behaviors. These results will inform new strategies to prevent the spread of illnesses including Zika, dengue fever, and chikungunya by directly targeting the pathways that make these mosquitoes effective vectors for disease.